Transport Cycle and Inhibition of Human Na+-dicarboxylate Cotransporter NaDC3

PROJECT SUMMARY
The human high-affinity Na+-driven dicarboxylate transporter NaDC3 plays critical roles in physiology. The gene
of the transporter, SLC13A3, is expressed in the brain as well as other tissues. Located in the plasma membrane,
the transporter imports various dicarboxylates into the cell, including succinate, a-ketoglutarate (aKG) and N-
acetyl-aspartate (NAA). In addition to being intermediates of the TCA cycle, dicarboxylates imported by NaDC3
also function as signaling molecules in the cell. In the brain, NAA functions as a precursor for the synthesis of
both neurohormones and lipids and as an osmolyte in cell volume regulation and in axon-glial signaling. The
transporter is involved in a number of disorders, including the lethal Canavan disease, an early-onset CNS
condition with “spongiform” vacuolation of white matter in the brain, caused by the overloading of NAA in glial
cells. Inhibition of the dicarboxylate transporter is a possible treatment, and small-molecule inhibitors have been
identified. In this project, we aim (1) to characterize the structural basis of NaDC3’s substrate specificity. (2) to
study inhibition mechanisms. (3) to investigate the conformational changes between the outward- and inward-
facing transitions. (4) to understand the sodium—substrate energy coupling. By accomplishing these aims, we
will be able to understand the molecular mechanism of the human NaDC3 over its complete transport cycle,
including its Co—Ci conformational transition and substrate—sodium coupling mechanism. Comparison of the
inhibitor-binding sites in NaDC3 and other proteins will aid in the design of NaDC3 specific inhibitors to help
patients suffering from Canavan disease.

Public health relevance
NARRATIVE This project aims to illuminate the molecular mechanism of the human sodium-dicarboxylate transporter NaDC3 by structurally characterizing its complete reaction cycle. Structures of the protein with substrates and inhibitors bound will establish the structural basis of the transporter’s substrate specificity and the mechanisms of inhibition. Such knowledge will in turn help us to understand the signaling pathways that control cell fate and aid us in the design of therapeutics in treating Canavan disease and other disorders.